Elucidating the molecular mechanism of ENaC function

Project summary (from original application) The epithelial sodium channel (ENaC) fine-tunes Na+ and water balance and is the primary regulator of blood pressure and volume through Na+ reabsorption in the distal nephron. Thus, ENaC is a critical therapeutic target for kidney diseases and blood pressure control. Here we propose to develop a molecular model for ENaC function by determining high-resolution structures of ENaC in different functional states. Molecular studies of ENaC have proven difficult largely because ENaCs are labile, multimeric integral membrane proteins that are activated by proteolysis of inhibitory domains located in the extracellular domain; how these peptidyl tracts exert their effects remains unresolved. Our goal is to develop methods for expression and purification of ENaC in the uncleaved and cleaved conformations. We will apply these methods to elucidate structure-based mechanisms underpinning ENaC gating, ion permeation, and allosteric modulation by combining single-particle cryo-electron microscopy and electrophysiology, together with judiciously chosen biochemical and biophysical assays. The structures will offer key insight into the molecular basis of proteolytic activation of ENaC providing positions of the inhibitory domains and identifying critical regions that mediate ENaC activity yielding the first accurate blueprints for rational, structure-based therapeutic strategies.

Public health relevance
Project narrative (from the original application) The proposed research is focused on understanding how an indispensable class of ion channels, the epithelial sodium channels (ENaCs), works to control blood pressure and fluid volume in humans. By resolving the structures of these vital proteins, we will have a greater understanding of how this ion channel works, which will result in novel therapeutic strategies for kidney and blood pressure-related diseases.